2023 Basic Mechanisms to Clinical Trials in Brain Tumors Gordon Research Conference

Project Summary
Brain tumors are among the most lethal and devastating human cancers. Despite decades of advances in the
field, patient outcomes for brain tumors remain poor. However, there has been a recent surge of
multidisciplinary discoveries in this field that are likely to impact patient care in a momentous way. The goal of
the inaugural Basic Mechanisms to Clinical Trials in Brain Tumors Gordon Research Conference (GRC)
multidisciplinary international meeting is to discuss and debate cutting-edge concepts and breakthroughs in the
brain tumor field to help develop innovative, mechanism-based diagnostic, prognostic, and therapeutic
approaches that will significantly advance the care of brain tumor patients. The meeting will cover both
pediatric and adult brain tumors and will focus on (1) deciphering the mechanisms that control normal brain
development and how aberrations of such mechanisms produce disease, (2) studying how alterations in
molecular pathways (including genetic and epigenetic events) result in clinical phenotypes, (3) understanding
how the brain and immune microenvironment affect tumor initiation and growth, and (4) investigating how such
knowledge can be translated into improved patient care. Emphasis would be placed on new concepts in brain
tumor research, new technological and computational biology approaches, and new therapeutic modalities and
their challenges. Laboratory and clinical investigators would develop novel strategies to translate new findings
into novel clinical trials. Further, an important feature of the meeting will be bringing together eminent leaders
and women, minorities, persons with disabilities, early stage and early established investigators in the field, in
order to build relationships and provide mentoring and networking opportunities to cement the commitment of
the new generation of scientists and clinicians to the field and provide them with the tools to make a difference
in the lives of brain tumor patients, and create opportunities to explore potential collaborations. The meeting
will be extensively evaluated by participants, and their ideas and opinions will be discussed in an open meeting
and will be taken into consideration in planning for subsequent years.

Public health relevance
Project Narrative The goal of the inaugural “Basic Mechanisms to Clinical Trials in Brain Tumors” Gordon Research Conference multidisciplinary international meeting is to discuss and debate cutting-edge concepts and breakthroughs in the brain tumor field to help develop innovative, mechanism-based diagnostic, prognostic, and therapeutic approaches that will significantly advance the care of brain tumor patients in an all-inclusive environment. We will also strive to provide inspiration and opportunities to the next generation of scientists and emphasize diversity in science.